SANDIMMUNE AND OG37 325 IN PREVENTION OF RENAL ALLOGRAFT REJECTION

This protocol provided for the determination of iothalamate and iohexol renal clearances and hepatic cytochrome P450 3A enzyme activity in patients participating in a phase-III multicenter trial comparing the safety and efficacy of the cyclosporin analog, OG 37-325, to that of cyclosporin A in recipients of first renal transplants.